J: Penn State NRSA Training Core

Translation of scientific discoveries into effective clinical interventions and best practices to improve public health is a complex process transcending traditional disciplines. The goal of the Penn State Clinical and Translational Science Institute (CTSI) TL1 Training Core is to provide early career scientists with the interdisciplinary training needed to conduct collaborative translational research aimed at transforming knowledge to benefit human health. Our program provides opportunities for predoctoral trainees to gain a foundation in clinical and translational science (CTS) through competency-based, didactic, experiential, mentored training opportunities coupled with career development activities. Drawing students from both the College of Medicine (CoM) and University Park (UP) campuses, the TL1 program is a forum for communication, collaboration, and cross-fertilization of ideas among students from a variety of backgrounds and disciplines. In the past funding cycle (2016- 2019), we trained 27 students in our year-long program (22 PhD, 3 MD/PhD, 1 MD/MPH, 1 MD) and 40 students in our summer program (19 PhD, 21 MD). In this renewal application, we request support for 6 year-long trainees and 16 short-term trainees per year. Trainees in the 1-year program pursue studies leading to a certificate in Translational Science, a MS in Clinical Research, or a unique dual-title PhD in CTS. Training is customized via individual development plans and enhanced by externships and experiential clinical research, development of leadership, communication, and time management skills, and activities focused on team science, entrepreneurship, regulatory science, and community engagement. A short-term training is offered in summer to a mixed cohort of medical and graduate students who are introduced to the fundamental aspects of CTS in a highly interactive format while conducting mentored research projects. We now seek to enhance the TL1 program with aims to: 1) Expand and enhance Penn State's community of predoctoral trainees engaged in CTS by increasing cross-disciplinary training of students by working with the directors of existing undergraduate pipeline programs; 2) Provide customized, competency-based didactic and experiential training through externships and training in collaborative team science, coupled with career development activities, structured mentor/mentee training, and networking activities across CTSA Hubs with shared interests in rural health; and 3) Increase the quality and effectiveness of our CTS training using a data-driven decision-making approach involving assessment of the trainees, their mentors, and program outcomes.